Crosstalk to Histone Arginine Methylation

ABSTRACT
Eukaryotic gene expression requires both transcription factor binding to DNA and histone post-translational
modifications (PTMs). In many cases, how these PTMs are mechanistically connected to transcription are still
unclear. Transcription factor binding to chromatin–such as by growth factors like TGF or by the hormone-in-
ducible glucocorticoid receptor (GR)–initiates transcription. Histone acetylation is transiently deposited on chro-
matin during transcriptional activation and during ongoing transcription. In contrast, histone arginine methyla-
tion–lasting for days–is a stable PTM. The two major protein arginine methyltransferases, PRMT1 and 5, are
regulated by substrate acetylation and phosphorylation. Studying this PTM crosstalk will illuminate how chro-
matin environments are transformed to establish and maintain gene expression. We can now transform our
understanding of how inducible transcription factor binding works together with both dynamic and long-lasting
PTMs to encode transcriptional programs. We hypothesize that PRMT1 and PRMT5 link inducible transcrip-
tional activation to a persistent chromatin environment. This hypothesis is compatible with a feed-forward
model of chromatin state maintenance, transferring gene activation through multiple histone PTMs. We will test
this hypothesis in the following specific aims: 1) How is stable histone arginine methylation regulated by transi-
ent PTMs? We will determine biochemical, enzymatic and structural mechanisms of PRMT1 and PRMT5 regu-
lation by histone substrate PTMs, like acetylation and phosphorylation. 2) How do transient histone PTMs co-
operate with PRMTs to regulate transcription? We will determine how PRMT1 or PRMT5 activity coupled with
histone phosphorylation or acetylation affects inducible transcription. 3) Does inducible transcription establish a
persistent chromatin environment? We will determine if inducible transcription is persistent past removal of the
initial stimulus. The ultimate goal and overall impact of this proposed project is to determine how transcriptional
and chromatin-based memory is established and maintained by combinatorial histone modifications. This study
will provide mechanistic insight for the clinically critical glucocorticoid signaling pathways, and it will build new
understanding of the understudied, but druggable, arginine methyltransferase family. This project will move the
field forward in the following ways: 1) it will establish a new paradigm reconciling the long-standing debates
over the role of histone PTMs in relationship to transcription factors in transcriptional regulation; 2) we will un-
derstand the biochemical mechanisms and biological implications of crosstalk between transient histone PTMs
and stable histone arginine methylation; 3) we will understand how hormone-inducible chromatin environments
are both established and maintained.

Public health relevance
NARRATIVE Epigenetics is a phenomenon important for an overall increase in the complexity of the genome without changes in gene sequence. How epigenetic regulation of gene expression is implemented by the cell is a critical question. This work will have significance for diagnosis and therapies for many pathologies. Furthermore, this work is significant for understanding normal cellular function.